HMPV/RSV co-infection: effects on replication and viral spread

Respiratory syncytial virus (RSV) and human metapneumovirus (HMPV) are important respiratory viruses which
cause significant morbidity and mortality, particularly in pediatric, elderly and immunocompromised patients.
Sensitive molecular techniques show that patients with respiratory infections are frequently infected with more
than one viral pathogen. In the case of RSV and HMPV co-infections, while some studies found no or limited
impact of co-infection, other research strongly indicates that RSV-HMPV co-infection has a deleterious effect on
the course of disease and severity of symptoms. However, few studies have examined the molecular details of
co-infection by these two important pathogens. Thus, the impact of RSV/HMPV co-infections remains a critical
area for continued study, but relatively little is known about the mechanisms by which co-infections may affect
the steps of the viral lifecycle. Viral interference through triggering of innate immunity and also competition for
cellular resources have been studied for their roles in co-infection, and very recent work suggests that hybrid
viral particles can form between influenza and RSV. Our preliminary studies of HMPV/RSV co-infection
demonstrate that inclusion bodies (IBs), which are key regions for viral transcription and replication, can contain
both RSV and HMPV genomes in co-infected cells, indicating a shared replication compartment. Our overall
hypothesis is that HMPV/RSV co-infection affects both virus replication and virus spread. To test this, we will
pursue two Specific Aims, using a range of experimental approaches and the wealth of reagents we have created
for the examination of pneumovirus infection. First, we will dissect the effect of HMPV/RSV co-infection on IB
formation, dynamics and viral replication, including careful analysis of IBs over the course of infection and
analysis of viral transcription and replication at the global and single cell level. Second, we will determine the
effect of HMPV/RSV co-infection on potential formation of functional hybrid virus particles. In addition, we will
examine whether a unique pathway for cell-to-cell spread which we have characterized for HMPV is also utilized
by RSV during co-infection. These important experiments will elucidate new molecular consequences of viral co-
infection, providing insight that may inform studies of additional respiratory viruses and lead to new ways to
target respiratory virus infections.

Public health relevance
Patients with respiratory infections are frequently found to have more than one virus, but the impact of viral co-infection remains poorly understood. This work will examine the interactions between respiratory syncytial virus and human metapneumovirus during infection of the same cell, particularly focusing on key steps in the viral life cycle. These studies will provide molecular insights that will also inform examination of other respiratory virus co-infection, and may lead to novel therapeutic targets and treatment options.